CHEMICAL AND STRUCTURAL INVESTIGATIONS OF NUCLEIC ACIDS AND RELATED MOLECULES

This project has the objective of understanding the chemistry and structure of nucleic acids and relating this knowledge to the biological functions of these molecules. Methods used include chemical synthesis of defined sequence DNA fragments and of enzyme substrates, enzymatic synthesis of polynucleotides, study of nucleic acids by circular dichroism, ultraviolet, infrared, and nuclear magnetic resonance spectroscopy, study of thermal transitions and dependence of physical properties on solution conditions. Subjects of investigation include factors which determine the stability of helical complexes, specificity of nucleic acid interactions, location and affinity of binding sites.